Robust and Interpretable Multimodal Machine Learning Models for Diagnosis and Prognosis of Prostate Cancer

ABSTRACT
Prostate cancer is the second leading cause of cancer death and affects about 13 out of 100
American men. The standard diagnosis approach for prostate cancer incorporates prostate specific-
antigen (PSA) blood test, digital rectal examination and biopsy, and, recently, the Prostate Imaging
Reporting and Data System (PI-RADS) that localizes and stratifies the risk of lesions in biparametric
MRI (bpMRI) images. Detection of clinically significant cancer (csPCa) remains a challenge, resulting
in over- and underdiagnosis. Thus, accurate diagnosis and staging of prostate cancer will have a
significant impact on successful treatment planning and clinical management. As large-scale imaging
datasets become widely available in clinical settings, more prostate cancer studies are adopting
machine learning (ML) and deep learning (DL) techniques. However, the common approach in the
existing studies has a drawback of using imaging findings, e.g., lesion size and radiomics features.
This project aims to implement and validate cutting-edge DL-based frameworks for the diagnosis and
prognosis of prostate cancer while fully utilizing imaging data and clinical scores (e.g., initial PSA
level and prostate genomic score). The proposed project will use state-of-the-art DL architectures
such as U-Net, image transformer and neural additive model to develop frameworks for robust DL-
based prostate and zonal anatomy segmentation (Aim 1), prediction of a csPCa probability map (Aim
2), and forecast of biochemical recurrence using interpretable multimodal DL framework (Aim 3). We
expect these frameworks will offer novel techniques adapted for prostate cancer, unique and
interpretable features from multimodal markers to better understand diagnosis and prognosis, and will
eventually help guide treatment selection and clinical management. This project will build on Dr. Kim's
quantitative background in modeling and analysis of neuroimaging data. During the project, Dr. Kim
will gain clinical expertise in prostate cancer via formal training driven by coursework (e.g., oncology
and biology) and research mentorship. Through the K25 award, Dr. Kim will lay the groundwork for
establishing an independent research program of computational methods for prostate cancer.

Public health relevance
PROJECT NARRATIVE The standard clinical diagnosis approach and existing studies show limited performance in predicting clinically significant prostate cancer. This project aims to develop diagnosis and prognosis tools that will have a positive impact on successful treatment planning and clinical management. The proposed project will utilize sophisticated machine learning and deep learning techniques for robust prostate and zonal segmentation, accurate prediction of a cancer probability map, and interpretable biochemical recurrence prognosis using multimodal data.